Endovascular ChemoFilter to Reduce Doxorubicin Toxicity during Intra-Arterial Chemotherapy

PROJECT SUMMARY
Dosing of chemotherapeutics is limited by systemic toxic side effects. We are developing a new class of image-
guided temporarily deployable, endovascular catheter-based medical devices that selectively remove specific drugs from the
blood stream to reduce systemic toxicities. The proposed ChemoFilters incorporate specialized materials that bind target
drugs in situ through a variety of mechanisms. During intraarterial chemotherapy (IAC) infusion to a target organ (e.g., a solid
organ containing a tumor), excess drug not trapped in the target organ passes through to the veins draining the organ and
then is circulated to the rest of the body, causing toxicities in distant locations. By temporarily deploying a ChemoFilter in the
vein(s) draining the organ undergoing IAC, we seek to bind excess drug before it can escape to cause systemic toxicity. The
ChemoFilter would then be removed in the interventional radiology suite shortly after the IAC procedure, thus removing
excess drug from the patient. Although paired intraaterial infusion and venous filtration can theoretically be used for any drug
that has its site of therapeutic action in one location and its site of dose-limiting toxicity in another location, the most compelling
application for this technology is increasing efficacy and safety of locoregional cancer chemotherapy.
Primary and metastatic liver tumors are among the top three causes of cancer death worldwide. Image-guided
transarterial chemoembolization (TACE), a form of IAC, cost-effectively increases survival in this population. Doxorubicin
(Dox) is a low-cost, highly effective, chemotherapeutic agent frequently used in IAC. Dox use is limited by systemic toxicities,
most importantly irreversible cardiac failure. Dox follows a therapeutic linear dose-response model, in which increasing dose
linearly increases tumor cell kill, providing motivation for higher-dose Dox therapy. Our initial project has yielded ChemoFilters
that can reduce Dox deposition in the heart by 46% in animal models. We seek to build upon that success by designing,
building, and testing new devices that can be more easily navigated to the hepatic veins in human patients.
Prototype ChemoFilters will be modeled, built, validated in vitro for efficacy, and tested in vivo in a large animal model
for navigability in Phase I by experienced teams from Filtro, Inc and UCSF. In phase II, the optimized devices from phase I
will then be tested for efficacy and safety in a large animal model and a first-in-man safety and efficacy study in patients with
unresectable liver cancer will be planned and initiated. Achievement of these aims will create new minimally invasive medical
devices that should markedly increase the efficacy of image-guided locoregional intraarterial chemotherapy by lowering
systemic drug concentrations and reducing systemic toxicities for the usual dose of Dox as part of TACE. Completion of this
study will poise the ChemoFilter technology for a pivotal clinical trial that would assess Dox dose escalation in any given
IAC/TACE procedure to achieve better local tumor control in fewer IAC/TACE sessions.

Public health relevance
PROJECT NARRATIVE We propose a paradigm shift in cancer therapy: ChemoFilter, an endovascular catheter-based medical device that will be inserted under image guidance into the veins of the body to directly filter specific chemotherapy drugs out of the blood stream after these drugs have had their effect on a tumor but before they have caused systemic toxic effects. ChemoFilter would help patients fight cancer by minimizing drug toxicity, allowing for high-dose therapy to better treat their disease and improve survival. Patients suffering from primary and oligometastatic liver cancers are the first targets for this device.